Administrative Core (A-Core)

Project Summary/Abstract: Administrative Core (A-Core)
This Program, led by an overall Program Director, is comprised of three Projects and three Cores. The proposed
program of research examines the associations of technology and digital media (TDM) with preschool-aged
children’s development and health outcomes. The Administrative Core (A-Core) is the central organizing body
for the Program. Its goal is to successfully coordinate the activities of the Projects and Cores in a way that
facilitates teamwork, cooperation, and, ultimately, synergy in an efficient, cost-effective manner. The A-Core has
5 Specific Aims that were carefully constructed with this goal in mind. Specific Aim 1 begins this process by
establishing a management plan for the overall Program. The plan consists of an Executive Leadership Team
comprised of one Lead from each Project or Core, a program-wide communication and training plan, an external
scientific advisory board, and a data safety and monitoring board. Specific Aim 2 will create a secure, centralized
management system to house key documents and promote an atmosphere of transparency by providing ready
access to key study documents. Specific Aim 3 will ensure Program activities are consistent with existing policies
and procedures of both the Children’s Nutrition Research Center and the Department of Pediatrics at Baylor
College of Medicine. Although Projects 1 and 3 will independently recruit participants for their respective
Projects, Specific Aim 4 will help ensure consistency by coordinating and monitoring overall recruitment. And
finally, Specific Aim 5 will develop risk mitigation plans that address risks to both participants and faculty/staff.
By establishing a framework for promoting synergy among both the team and the Projects and Cores, a feedback
loop will be created whereby team synergy and Project/Core synergy interact to promote overall Program
synergy, thereby leading to greater Program impact. This approach will also create the framework for a
sustainable system that will enable continuation of this research. Ultimately, the impact of this work is that it will
contribute to more precise TDM guidelines. The proposed research is consistent with NICHD’s overall mission
as well as the overall intent of RFA–HD-22-009.